Incident Hemodialysis Electrolyte Analysis and Rhythm Trends (IHEART)

Project Summary/Abstract
This R03 award will contribute to providing Dr. Katherine Ravi with the resources, additional training
and protected time necessary to achieve her goal of becoming an independent clinical investigator. Dr. Ravi
has completed her Master of Public Health and will continue to benefit from her outstanding institutional
support and resources through the pursuit of didactic courses for continued formal education in biostatistics
and study design through Harvard Catalyst and the Harvard Master of Medical Sciences in Clinical
Investigation program, research conferences, leadership courses and training in the responsible conduct of
research. These will complement her strong institutional support and will build upon her prior training in human
investigation.
Well over a million patients have initiated hemodialysis in the last decade in the United States alone,
and their mortality rate during their first year on hemodialysis is nearly 20%. The risk of death is particularly
high in the first 120 days after starting hemodialysis, with cardiac arrest of unknown cause occurring at a rate
of 5.2 per 100 person-years during this period. It has been demonstrated that the first week of hemodialysis is
associated with the highest rate of cardiovascular events. However, few studies have assessed cardiac
rhythms during the particularly vulnerable hemodialysis initiation period. This R03 proposal (PAR-22-129),
entitled “Incident Hemodialysis Electrolyte Analysis and Rhythm Trends (IHEART)” will investigate how cardiac
rhythm morphology associated with sudden cardiac death evolves during the early stages of hemodialysis, and
how serum electrolyte levels are associated with these changes.
We will perform a cohort study on 30 patients initiating hemodialysis; we will recruit 33 patients total to
allow for a 10% dropout rate. In Aim 1, we will compare QTc duration, ventricular ectopy, heart rate variability
(all markers of sudden cardiac death and arrhythmia risk) and arrhythmia in week 1 and week 5 of
hemodialysis initiation. In Aim 2, we will assess how electrolytes are associated with these changes, with a
focus on ionized calcium levels.
During this award period, Dr. Ravi will employ her excellent academic resources and mentorship at
Brigham and Women’s Hospital to continue in her pursuit of skills and expertise required to attain R01 funding,
allowing her to continue her critically important research and to train future clinical investigators.

Public health relevance
Project Narrative Over a million patients have initiated hemodialysis in the last decade in the United States alone, with approximately 20% dying within the first year on the therapy. The risk of mortality due to cardiac arrest is particularly high during the early weeks of hemodialysis. Our proposal will investigate how electrocardiographic patterns associated with sudden cardiac death evolve during the early phase of hemodialysis initiation and how these patterns correlate with electrolyte changes, focusing on ionized calcium levels, to better understand and potentially mitigate this significant risk.